Genomic control of gene regulatory networks governing early human lineagedecisions

ABSTRACT (unchanged from the parent grant)
Predicting the impact of genomic variation requires quantitative modeling to deconstruct the interplay
between multiple individual variants and to determine their combined effects on gene regulatory networks
(GRNs) that control cell state and cell function. We focus on the GRNs that control early human development
as a paradigm. Arguably the most important lineage decision during mammalian development is the decision of
epiblast cells to exit the pluripotent state (a state when the cells have the potential to give rise to all somatic
cells and germ cells), and differentiate into one of the three primary germ layers, the endoderm, mesoderm,
and ectoderm. This pluripotent state and the trilineage differentiation can be captured using cultured human
embryonic stem cells (hESCs). Much attention has focused on the GRNs underlying the maintenance of the
self-renewing pluripotent state, but the GRNs governing hESC trilineage differentiation remain largely
unexplored. We previously conducted genome-scale CRISPR/Cas screens to discover protein-coding genes
that regulate the transition of hESCs to definitive endoderm. Based on the genomic and genetic data and
machine learning (gkm-SVM sequence analysis), we expanded our initial simple two transcription factor (TF)
model to a multiple TF cooperative model. Here we propose an integrative approach examining the hESC
transition to definitive endoderm, mesoderm and neuroectoderm germ layer identities to improve the
generalizability of GRN models. We will perform quantitative genomic and proteomic measurements with high
temporal and single-cell resolution. These quantitative measurements will be combined with perturbation of key
GRN elements, core TFs and their target enhancers, to inform the generation of dynamic GRN models. To
further improve the precision of our new GRN models, we will map cell trajectories during state transitions
through lineage tracing combined with scRNA-seq. Beyond hESC guided differentiation, the physiological
relevance of enhancers will be further interrogated in human and mouse organoids (gastruloids) and mouse
embryos. We will then apply innovative new computational and algorithmic methods to our multimodal
experimental data to generate GRN models, aiming to learn generalizable principles underlying the
contribution of genomic variants to cellular and ultimately organismal phenotypes. Developing GRN models for
the exit of pluripotency and the acquisition of germ layer identities involves dynamic modeling of the cell state
transition, which will not only inform our understanding of early human development, but can also serve as the
basis for construction of generalizable GRN models for biological transitions during embryonic development,
adult tissue homeostasis and regeneration as well as inappropriate cell fate transitions that occur in
pathological conditions such as cancer.

Public health relevance
PROJECT NARRATIVE (unchanged from the parent grant) This project will construct models of gene regulatory networks controlling early human development by taking an integrative approach involving perturbation of core regulatory network elements, quantitative genomic and proteomic measurements with high temporal and single-cell resolution, and systems level analyses. Knowledge gained from the study will provide a conceptual framework for dissecting gene regulatory networks during cell state transitions, and reveal general features of genomic variants that contribute to cellular and organismal phenotypes.